Systematic identification of enhancers to target the breadth of excitatory and inhibitory neuronal cell types in the cerebral cortex

PROJECT SUMMARY
In this proposal we aim to identify gene regulatory elements that permit the targeting and
manipulation of brain circuit models of human brain function. Gaining genetic access to specific
neuron populations in nontransgenic animals and humans would enable targeted circuit
modulation for hypothesis testing and provide a means to evaluate the safety and efficacy of
circuit modulation for the treatment of epilepsy and psychiatric disorders. Our approach
capitalizes on our combined expertise in the development and maturation of brain cell-types and
circuits (Gord Fishell and Paola Arlotta), identification of CIS-regulatory elements that function
across species (Yating Wang), AAV engineering combined with large-scale screening methods
(Ben Deverman) and expertise at combining RNA and chromatin biology (Jason Buenrostro).
Our efforts will also benefit from an ongoing collaboration with John Reynolds at the Salk
Institute on observation and manipulation of cortical circuits during complex visual perception
tasks. This project will build upon success that we and others have had in identifying gene
regulatory elements that enable cell type-restricted gene expression when used within
recombinant adeno-associated virus (AAV) vectors. In particular, the pipeline for enhancer
discovery stemming from our recent UG3 grant provides us with the systematic for identifying
additional enhancer sequences that function in the context of the limited carrying capacity of
AAV. Here we aim to apply the novel high-throughput screening approach we devised in the
course of this UG3 for the rapid identification of a suite of enhancers that enable the study and
manipulation of genetically defined cell types and circuits across species. Our preliminary data
demonstrates that our enhancer identification strategy can yield novel and highly specific
enhancers that restrict expression to target populations. In addition, we have demonstrated that
it is possible to use the engineered AAV-PHP.eB capsid to screen enhancers across the brain
with a single noninvasive injection. These successes have highlighted the need for more rapid
and comprehensive assessment of putative enhancers. In addition, we will examine the
tolerance to neuronal activity manipulation within the target neuronal populations in several
species. This proposal will be transformative in devising methods to target and manipulate the
brain activity of specific neuronal cell populations across species, including human cell-derived
organoids.

Public health relevance
PROJECT NARRATIVE This project will identify gene regulatory elements that enable selective expression of activity modulators and sensors in specific neuronal populations using recombinant adeno-associated viral vectors (AAV). The novel AAV vectors developed during the course of this proposal will be screened and evaluated for their ability to enable the study and modulation of both excitatory and inhibitory cells within circuits of the cerebral cortex.